Molecular and Circuit Mechanisms of Memory Prevention and Removal

Project Summary
Nothing is more central to the human experience than memory, and no human capacity is more devastating
when it is lost. Memory has been intensely studied in basic and disease research for many decades but to my
knowledge we do not have any physical explanation of how memories alter complex behavior. This is in large
part because we do not have a mechanistic explanation of how most behaviors are executed in the first place,
but also because memory formation is best understood in brain regions like the hippocampus, which are far
removed from action control centers, which themselves are not well understood in the mammalian brain.
Drosophila courtship behavior stands out from other complex behaviors because it is exceptionally well
understood at the circuit level. Here I describe a new and robust paradigm for courtship learning in which the
memories appear to be formed, stored, modified, implemented, and erased within core courtship circuitry.
In both insects and mammals, dopamine has long been known to translate memory-relevant information from
the outside world into an internal teaching signal. In our new courtship learning paradigm we find that
dopamine signaling is both necessary and, under the appropriate circumstances, sufficient for memory
formation. I propose to test the hypothesis that dopamine-induced memory is written directly within courtship
circuitry, likely within a set of command neurons called P1. We will identify the specific dopaminergic neurons
required to write the memory, as well as localize the neurons that receive the dopamine signal. We will then
use our established activity monitoring and behavioral assays, together with the courtship wiring diagram, to
understand how memory alters the flow of information through behavioral circuitry. The results will provide new
insights into how memories directly impact behavioral decision-making, a goal that has been unachievable in
systems lacking detailed behavioral circuit maps. The conserved role of dopamine in memory writing suggests
that our findings will generalize to mammals.
Learning usually requires repetition or extreme events. This prevents the over-generalization that might occur
with single-trial learning. By analyzing the contributions of various known components of the courtship circuitry
to memory formation, we find a striking and novel role for a group of neurons, called mAL, in setting a
threshold for memory formation. mAL stimulation can even erase old memories, but only while they are being
recalled. I believe this is the first circuit-level manipulation that has been shown to disrupt memory
reconsolidation. I outline experiments designed to leverage this new behavioral paradigm and its circumscribed
neuronal populations to understand the nature of memory thresholding, maintenance, and removal in
behavioral circuitry at the molecular, circuit, and physiological levels. We will work to establish the new and
potentially transformative hypothesis that within populations of neurons that inhibit the execution of behaviors,
there exist subsets of neurons that can limit or even erase memories associated with those behaviors.

Public health relevance
Project Narrative: Despite its centrality to the human condition, susceptibility to disease, and decades of intense research, there are still many fundamental mysteries surrounding the biological basis of memory. I present a new, reductionist system that will allow rapid progress in our understanding of memory formation and removal. The preliminary findings in Drosophila show extensive molecular and phenomenological similarities to mammalian memory and identify a novel population of neurons that set the threshold for memory formation and control its removal.